CORE--ADMINISTRATIVE, STATISTICS, AND DATA MANAGEMENT

The objective of this core is to provide leadership and coordinate the work of the South Carolina Resource Center for Minority Aging Research. As specific aims this core will: 1. Provide leadership to the SC RCMAR; 2. Receive and make use of input from the Community and Scientific Advisory Boards; 3. Ensure that the cores interact to maximum benefit in order to develop and maintain community liaisons, recruit and retain minority participants, mentor and train new investigators and provide a liaison with affiliated institutions for training, and create the appropriate instruments and techniques for working with African Americans; 4. Oversee pilot study process and progress and track pilot investigators; 5. Provide biostatistical and data management support and access to state data through the state Office of Research and Statistics to all core and pilot projects; 6. Participate in annual meetings with other RCMARs to discuss progress and common problems and facilitate SC RCMAR investigators cooperation with the Coordinating Center (CC).